IGF::OT::IGF CORE INFRASTRUCTURE SUPPORT FOR SEER; 5/1/15-4/30/17

The aim of this Task Order modification is to support a pilot test of Native American/Alaska Native Data reporting. This pilot test will include the development of web-based methods of presenting this information.